Administrative Core

The success of the PPG is dependent upon effective communication and efficient interactions between project
members. This will be greatly facilitated by a centralized Administrative Core A, at the University of Pittsburgh.
Core A duties will be carried out by an Administrative Assistant (Ms. Donna Gaspich), under the direction of Dr.
David Rothstein (Core Director).
Specifically, the Administrative Core will be responsible for scheduling and coordinating monthly audio-visual
PPG lab meetings between Dr. Rothstein at the University of Pittsburgh and the PIs/Co-Is at Harvard Medical
School. In addition the Administrative Core will be responsible for scheduling site visits by Dr. Rothstein and
his post-doctoral fellow (three times yearly) to Boston for face-to-face PPG meetings with Principal
Investigators, Co-Investigators and post-doctoral fellows from each Project and Core B. One of these meetings
will also include the PPG Advisory Board. The Administrative Core will be responsible for all travel
arrangements and reimbursements for the participants.
The Administrative Core will also be responsible for the preparation of joint abstracts, manuscripts,
presentations, and progress reports for the PPG. Other responsibilities include accounting and tracking of
expenditures as well as the preparation of the annual budgets for the progress reports. Finally, Core A will be
responsible of coordinating the shipping of samples from Pittsburgh to the Expression Core B (Broad Inst.,
Cambridge MA) as well as coordinating shipping of other reagents or mice.
These duties will ensure seamless communications and interactions between the PI's and the Expression
Core, and promote effective input from the Advisory Board. Such interactions are key to the collaborative and
interactive environment and communications required for ultimate success of the PPG.